mDOT TR&D3 (Translation): Translation of Temporally Precise mHealth via Efficient and Embeddable Privacy-aware Biomarker Implementations

Principal Investigator: Kumar, Santosh
TR&D3: Translation of Temporally Precise mHealth via Efficient and Embeddable Privacy-aware
Biomarker Implementations
Lead: Dr. Emre Ertin, The Ohio State University; 10% effort (1.2 CM)
Abstract: The mHealth Center for Discovery, Optimization & Translation of Temporally-Precise Interventions
(the mDOT Center) will enable a new paradigm of temporally-precise medicine to maintain health and manage
the growing burden of chronic diseases. The mDOT Center will develop and disseminate the methods, tools,
and infrastructure necessary for researchers to pursue the discovery, optimization and translation of temporally-
precise mHealth interventions. Such interventions, when dynamically personalized to the moment-to-moment
biopsychosocial-environmental context of each individual, will precipitate a much-needed transformation in
healthcare by enabling patients to initiate and sustain the healthy lifestyle choices necessary for directly
managing, treating, and in some cases even preventing the development of medical conditions. Organized
around three Technology Research & Development (TR&D) projects, mDOT represents a unique national
resource that will develop multiple methodological and technological innovations and support their translation
into research and practice by the mHealth community in the form of easily deployable wearables, apps for
wearables and smartphones, and a companion mHealth cloud system, all open-source.
TR&D3 will develop, validate and disseminate algorithms, tools and software/hardware designs for translation of
temporally-precise mHealth interventions through resource efficient, real time, low-latency and privacy-aware
implementation of an array of digital biomarkers that can be deployed at scale. Our approach is centered around
a hierarchical computing framework that reduces the data into minimal modular abstractions called Micromarkers
computed at the edge devices (Aim 1). Modular Micromarker abstractions are used to compress task-specific
information relevant to biomarker computations at the edge devices while stripping nuisance variables such as
hardware biases/drifts and background levels not pertinent to inference. Our hierarchical computing framework
can be extended to implement high data rate sensor arrays at edge devices to be used at new point of care and
ambulatory settings. This is accomplished through integrating a compressive sensing pre-processor to achieve
signal acquisition in a resource constrained setting (Aim 2). Finally, TR&D3 will create computational
mechanisms and a general biomarker privacy framework to enable participant control over the privacy-utility
trade-offs during study design, data collection, and sharing of collected mHealth data for third party research
when data cross trust domains (Aim 3).
These technologies will be developed in collaboration with collaborative projects and will be disseminated to
service projects to ensure that TR&D3 technologies can solve real problems facing the health research
community and ensure the usability of these technologies by investigators who are external to the mDOT
investigating team. TR&D3 will synergistically work in partnership with the other TR&D projects, the Training and
Dissemination Core, and the Administration Core to maximize the societal impact of TR&D3 technologies.
1

Public health relevance
Principal Investigator: Kumar, Santosh TR&D3: Translation of Temporally Precise mHealth via Efficient and Embeddable Privacy-aware Biomarker Implementations Lead: Dr. Emre Ertin, The Ohio State University; 10% effort (1.2 CM) Public Health Relevance: Algorithms, tools and software designed by TR&D3 will make it possible for temporally-precise mHealth interventions to be deployed to participants’ personal devices with appropriate privacy controls and minimal effect on battery and processor resources. Doing so will transformatively improve health and disease outcomes by enabling patients to initiate and sustain the healthy lifestyle choices necessary to prevent and/or successfully manage the growing burden of multiple chronic conditions. 2